Lipid regulation of cellular signaling and protein-protein interactions

WONHWA CHO, PH.D.
PROJECT SUMMARY/ABSTRACT
Lipid regulation of cellular signaling and protein-protein interactions
Cellular proteins accomplish their functions through interactions with other proteins, forming complex
protein-protein interaction networks. Cellular protein-protein interaction typically involves small
modular protein interaction domains, such as Src-homology 2 and PSD95, Dlg1, ZO-1 domains.
Physiological significance of protein interaction domain-mediated protein-protein interaction networks
has been well supported by a large number of protein interaction domains encoded by human
genome and many human diseases, including cancer, caused by dysfunctional protein interaction
domain-mediated cellular processes. Interestingly, most protein interaction domains have moderate
binding affinity and a significant degree of promiscuity. This may be necessary for reversibility and
redundancy of cell signaling pathways but raises a fundamental question as to how high-fidelity
cellular function and regulation can be achieved through the protein interaction domain-mediated
protein-protein interaction. We have recently shown that membrane lipids, including cholesterol and
phosphoinositides, coordinate and regulate protein-protein interaction by directly and specifically
interacting with protein interaction domains. This important new discovery and our innovative in situ
quantitative lipid imaging technology provide us with a unique and unparalleled opportunity to
elucidate the mechanisms by which lipids orchestrate spatiotemporal specificity of protein-protein
interaction and cell signaling and develop new strategies to modulate these processes. Given the
importance of protein interaction domain-mediated protein-protein interaction and cell signaling in
health and disease, our proposed research should have a major impact on broad areas of biology and
medicine and lay the foundation for a pioneering and innovative drug discovery strategy for human
diseases, most notably cancer.

Public health relevance
WONHWA CHO, PH.D. PUBLIC HEALTH RELEVANCE STATEMENT Lipid signaling is an important target for drug development for diverse human diseases, including cancer. Based on our recent research showing that membrane lipids directly and specifically control cellular activities of diverse proteins that are critically involved in cancer, we propose to elucidate the mechanisms underlying complex lipid-mediated cell regulation and develop drugs targeting lipid- protein binding interfaces. Given the general and fundamental importance of lipid signaling, our pioneering, innovative research should have major impact on broad areas of biology and medicine.